Dynamic dyadic parent-child interactions among CI-using children

PROJECT SUMMARY
Spoken language outcomes for deaf children who use cochlear implants (CIs) are highly variable, with many
children who use CIs lagging behind their peers with normal hearing. Among the identified causes of this
variability is parental input, with evidence suggesting that variation in parental input may directly relate to
children's post-CI language outcomes. Parent-based language interventions, including coaching parents on
their language input, have been proposed as a means of improving parental input and thereby improving
children’s language outcomes. However, we currently do not know how parental language and responsivity
change over time following implantation, nor do we know how parental language influences child language
over time following implantation. This lack of understanding regarding parent-child dynamic relationships is a
critical gap in our ability to create effective parent-based interventions to improve post-CI language outcomes.
The proposed research will address this gap in our knowledge by identifying the dynamic and dyadic
relationships between parental language input and child language development post-CI. To attain this goal, we
will conduct a secondary analysis of the Childhood Development after Cochlear Implantation (CDaCI)
database, including coding parent language microstructure, parental facilitative language use, maternal
sensitivity, and child spontaneous expressive language. These data will be analyzed using bivariate change
score models, allowing us to identify the dynamic developmental relations between parental input and child
language. Aim 1 will examine how parental language, maternal sensitivity, and child language change over
time. Aim 2 will test the hypothesis that parental input and child language have bidirectional influences. The
obtained data will provide initial evidence that parental language and child language are mutually reinforcing.
These data will provide preliminary support for an R01 application to develop and validate an intervention
targeting parental input to support language growth in prelingually deafened children, including children from
historically marginalized communities, advancing our long-term goal to optimize language and literacy
outcomes for all children with hearing loss.

Public health relevance
PROJECT NARRATIVE The proposed research will indicate how parental inputs and child language co-develop over time. These results will inform our understanding of language development following cochlear implantation, and may lead to effective interventions to improve long-term language outcomes for deaf children who use CIs. This research is consistent with the mission of the NIDCD because it will help us understand language development for children who use CIs and may lead to improved language outcomes for this population.